SAFETY AND IMMUNOGENICITY OF 3 DOSE LEVELS OF GP120 WITH OR WITHOUT MTP-PE

To evaluate the safety and immunogenicity of a recombinant envelope protein of human immunodeficiency virus-1, gp120, combined with an adjuvant, MTP-PE/MF59 in healthy volunteers.